Personal Healthcare Networks of Transgender and Gender-Diverse Adults After Gender-Affirming Surgery

Transgender and gender-diverse (TGD) individuals face substantial health disparities compared to cisgender
(i.e., non-TGD) people, including increased depression, anxiety, substance use, suicidal thoughts and
attempts, chronic disease, and HIV. While gender-affirming care, such as surgery, can improve mental health,
TGD people live long and complex lives beyond gender-affirming surgery; this intervention does not alleviate
the deeply-rooted systemic stigma and prejudice towards TGD people that leads to chronic minority stress and
negatively affects their health outcomes. Furthermore, most previous literature focuses on life before or
immediately after gender-affirming interventions. To fill these gaps in knowledge, the proposed study seeks to
identify barriers and facilitators to resilience for TGD people after gender-affirming surgery. In particular, access
to care is a systems-level resilience factor with great potential to intervene upon the health of TGD people
across the life course. However, evidence indicates that TGD individuals delay and avoid needed healthcare
due to experiences of stigma in healthcare settings. Moreover, current data about access to care in this
population is insufficiently detailed. To capture the complex systems and interpersonal factors that intersect in
accessing healthcare, this study proposes a unique application of egocentric social network analysis to
operationalize access to care as a multifaceted and relational process. By conceptualizing a “personal
healthcare network” composed of the varied and multidisciplinary healthcare professionals that a person
engages with when seeking healthcare, this research will quantitatively and qualitatively describe concepts that
are often insufficiently measured using dichotomous variables. This study focuses on TGD patients’ insider
perspectives about their structures of care, centering the experiences of this marginalized population to provide
essential insights that are not available in the current literature or with previously-used methods. The specific
aims are to (1a) characterize the personal healthcare networks of TGD adults after gender-affirming surgery (N
= 100), (1b) examine associations between network characteristics and participant outcomes in mental and
physical health, and (2) qualitatively explore TGD people’s experiences of building and accessing a network of
healthcare providers after gender-affirming surgery (N = 24). These aims will be achieved by adding new
quantitative items to data collection in an existing study of TGD adults one year after gender-affirming surgery,
and then recruiting a qualitative subsample from this group for semi-structured interviews. These aims are
aligned with NINR’s Research Lenses of Health Equity and Systems and Models of Care. Through the
proposed research and training plan, the applicant will receive top-tier mentorship in a research-intensive
environment at Columbia University School of Nursing, setting them on the path to becoming an independent
nurse investigator. This research will be a significant contribution to access-to-care methods and address the
dearth of literature on TGD resilience to minority stress after gender-affirming surgery.

Public health relevance
PROJECT NARRATIVE Transgender and gender-diverse (TGD) individuals in the United States face substantial stigma, prejudice, and health disparities that may be mitigated by gender-affirming care, but little is known about resilience factors to support TGD health in the years after gender-affirming surgery. Access to healthcare is a proposed element of TGD resilience, but many TGD people are likely to avoid or delay care due to stigma, and existing research about TGD access to care is lacking both rich description and a focus on the crucial period after gender- affirming surgery. To inform future interventions for TGD health equity across the lifespan, the proposed study will leverage an existing study of TGD individuals after gender-affirming surgery to characterize their access to care through “personal healthcare networks” of healthcare professionals, analyze associations between these networks and physical and mental health, and qualitatively explore their experiences of navigating stigma and minority stress in building and accessing these networks.